Psychobiological Regulation of Cell-Free Mitochondrial DNA in Human Saliva

PROJECT SUMMARY
Mitochondria are an emerging signaling organelle involved in stress regulation and mental health. Identifying
mechanisms of mitochondrial signaling, including secreted molecules and their dynamic regulation, will provide
the necessary tools to elucidate their role in stress pathophysiology and other disease conditions. We and others
have recently established that mitochondria can release their own genome as cell-free mitochondrial DNA (cf-
mtDNA), a potentially immunogenic molecule present in varying levels in human blood, particularly under
conditions of psychological stress and psychopathology. Building on our recent discovery that cf-mtDNA is
detectable in human saliva, we now propose foundational studies necessary to establish saliva cf-mtDNA as a
useful marker for human research. Based on our preliminary studies, this 2-year R21 proposal aims to i) map
the natural awakening response and diurnal variation of cf-mtDNA in healthy adult premenopausal women and
in men; ii) define the association between cf-mtDNA and key steroid hormones with already well-defined diurnal
rhythms, including cortisol; iii) leveraging already-collected saliva samples from a stress induction protocol,
establish whether saliva cf-mtDNA is inducible by acute socioevaluative stress; and iv) whether saliva cf-mtDNA
mirrors blood levels or whether cf-mtDNA is independently regulated in these two different biofluids. Together,
these studies will establish potential sex differences in saliva cf-mtDNA dynamic across time scales, and provide
the necessary basis to establish cf-mtDNA as a marker of mitochondrial stress in both mechanistic and
epidemiological studies.

Public health relevance
NARRATIVE Recent evidence suggests that psychological stress affects mitochondria, which release their own DNA into the circulation, representing a potential mechanism whereby psychological stress results in inflammatory and metabolic dysregulation. We have discovered that cell-free mtDNA (cf-mtDNA) is also accessible in human saliva and we propose foundational studies to map potential diurnal variation in cf-mtDNA, its correlation with blood levels, and to examine its association with steroid hormones. This study will generate the empirical basis necessary to employ saliva cf-mtDNA as a biomarker of mitochondrial stress in future studies linking stress exposure and mitochondrial signaling in human studies.